Scientific Information Management and Literature-Based Evaluations for the DTT - Systematic Review of Woodsmoke

The Division of Translational Toxicology performs systematic reviews of literature to assess the potential for adverse effects on human health by agents, substances, mixtures, or exposure scenarios, based on information about human exposure. The findings of these reviews are generally focused on either cancer or non-cancer effects and published as monographs. This review on woodsmoke was conducted in support of the congressionally mandated Report on Carcinogens (RoC). The RoC lists substances that pose a cancer hazard for people living in the United States, and also documents information related to the cancer hazard evaluation of substances as potential new listings in the report. Keywords: systematic review, toxicology, epidemiology, exposure, cancer effects.